UNC MACS/WIHS Combined Cohort Study Clinical Research Site

PROJECT SUMMARY/ABSTRACT
This application proposes to establish The University of North Carolina at Chapel Hill as a Clinical Research
Site (CRS) for the Multicenter AIDS Cohort Study (MACS)/Women’s Interagency HIV Study (WIHS) Combined
Cohort Study (MACS/WIHS-CCS). The proposal represents a collaborative effort between investigators from
The UNC Institute for Global Health and Infectious Diseases, Center for AIDS Research, UNC Gillings School
of Global Public Health, Lineberger Comprehensive Cancer Center, Eshelman School of Pharmacy, and Cecil
G. Sheps Center for Health Services Research.
We propose to rapidly establish the UNC MACS/WIHS-CCS CRS, contribute meaningfully to the MACS/WIHS-
CCS (CCS) Unified Science Agenda, and undertake ambitious research that encompasses pulmonary,
cardiovascular, neurocognitive, and other HIV-related comorbidities; HIV pathogenesis/cure; social
epidemiology and health outcomes; behavioral research; and advanced epidemiologic methods.
We aim to: (1) Enroll 310 male and female participants who reflect the HIV epidemic in the southeastern US,
and re-consent current WIHS enrollees for participation in the CCS; (2) Lead critical components of the CCS
Unified Science Agenda; (3) Support all aspects of the CCS Science Agenda at the UNC CRS.
By contributing a representative population of men and women, innovative science, and a strong,
multidisciplinary cadre of investigators, UNC will enhance the efforts of the CCS, expand the range of
questions that can be addressed and, in collaboration with the entire group, improve the health of men and
women with or at high risk for HIV infection.

Public health relevance
PROJECT NARRATIVE This application proposes to establish The University of North Carolina at Chapel Hill as a Clinical Research Site (CRS) for the Multicenter AIDS Cohort Study (MACS)/Women’s Interagency HIV Study (WIHS) Combined Cohort Study (MACS/WIHS-CCS). We propose to rapidly establish the UNC MACS/WIHS-CCS CRS, contribute meaningfully to the MACS/WIHS-CCS Unified Science Agenda, and undertake ambitious research that encompasses pulmonary, cardiovascular, neurocognitive, and other HIV-related comorbidities; HIV pathogenesis/cure; social epidemiology and health outcomes; behavioral research; and advanced epidemiologic methods. By contributing a representative population of men and women, innovative science, and a strong, multidisciplinary cadre of investigators, UNC will enhance the efforts of the MACS/WIHS-CCS, expand the range of questions that can be addressed and, in collaboration with the entire group, improve the health of men and women with or at high risk for HIV infection.